DP21-001 The Pennsylvania Pregnancy Risk Assessment Monitoring System (PA PRAMS) Project

R&R Other Project Information
Pennsylvania PRAMS Project
Component A: Core Surveillance
Project Summary/Abstract:
The purpose of the Pregnancy Risk Assessment Monitoring System (PRAMS) is to
provide unique jurisdiction-specific and population-based data on people recently
delivering a live birth or stillborn infant to examine the association between risk factors
and maternal and infant outcomes, explore disparities, and compare health indicators
across jurisdictions. A Centers for Disease Control and Prevention (CDC) grantee since
2007, the Pennsylvania (PA) PRAMS project’s mission is to promote the collection,
analysis, and dissemination of population-based data of high scientific quality and to
support the use of data to develop policies and programs in order to reduce maternal
and infant morbidity and mortality. This mission is accomplished in partnership with the
Bureau of Health Statistics and Registries, the Bureau of Informatics and Information
Technology, and Title V Maternal and Child Health Services Block Grant program. The
goals for the PA PRAMS project for the next five-year period are:
• To monitor the prevalence of maternal behaviors and experiences before, during,
and after pregnancy and investigate emerging issues;
• To identify and address health inequities and the related structural and
institutional barriers affecting the health outcomes of people with a live birth and
their infants;
• To analyze and disseminate PA PRAMS data to monitor progress on Title V and
Healthy People performance measures and drive the development or
modification of programs and policies to improve the outcomes of the maternal
and child health population.
Guided by the PRAMS Committee, analysis, translation, and dissemination of PA
PRAMS data to both PA Department of Health stakeholders and external partners will
be used to inform and drive programs, policies, research, and systems change to
improve inequities in maternal and child health outcomes throughout PA.

Public health relevance
R&R Other Project Information Pennsylvania PRAMS Project Component A: Core Surveillance Project Narrative: The Pennsylvania Pregnancy Risk Assessment Monitoring System (PA PRAMS) project collects information on selected maternal behaviors and experiences occurring before, during, and after pregnancy from a monthly random sample of residents with a live birth. The project’s mission is to promote the collection, analysis, and dissemination of population-based data of high scientific quality and to support the use of data to develop policies and programs in order to reduce maternal and infant morbidity and mortality. It is anticipated implementation of the PA PRAMS project over the next five-year period will continue to result in timely, high quality data to monitor prevalence of, and inequities in, maternal health behaviors and experiences.